Role of RAF1 in human cardiogenesis and congenital heart defects

Project Summary
The goal of this project is to discover fundamental RAF1-dependent mechanisms that regulate early steps of
cardiogenesis to further delineate the molecular basis of congenital heart defects (CHDs) and cardiomyopathies.
RAF1 (or CRAF) is a serine/threonine-specific protein kinase that is ubiquitously expressed and controls cell
proliferation, apoptosis, cell differentiation, and oncogenic transformation. Newborns with RAF1 germline loss-
of-function have been recently identified and present with severe CHDs. Moreover, infants with Noonan
syndrome (NS) associated RAF1 mutations present with obstructive hypertrophic cardiomyopathy and a variety
of CHDs. Currently, no specific treatment exists for NS children with CHDs or cardiomyopathy, therefore there
is an urgent need to understand the molecular mechanisms underlying cardiac developmental defects to identify
specific therapeutic strategies. Using hiPSCs and cardiac-directed differentiation as a developmental model, we
discovered that RAF1 was required for human cardiogenesis by regulating cardiac mesoderm specification and
showed that NS RAF1 mutations impacted this process. How RAF1 regulates early human cardiogenesis
programs and how NS mutations, such as those found in the RAF1 gene, impair cardiac development remains
elusive. Hence, the overall goal of this proposal is to discover signaling, genetic and epigenetic networks
modulated by RAF1 and impacted by NS RAF1 mutations during early cardiogenesis. We seek to perform an
unprecedented in-depth investigation into the signaling and epigenetic networks altered by loss of RAF1 or NS
RAF1 mutations at early stages of human cardiac differentiation. Toward that goal, we have compiled a “toolbox”
of hiPSC lines generated by genome editing (CRISPR-Cas9) to enable a comprehensive analysis of gain-and
loss-of-function phenotypes, with a solid track record for such analyses. Our proposal will break ground beyond
current knowledge by achieving the following aims: Aim 1: Discover the function of RAF1 in early human
cardiogenesis. Aim 2: To interrogate the impact of Noonan syndrome RAF1 mutations on human cardiac
development. Aim 3: Delineate the role of nuclear RAF1 in early human cardiogenesis. Successful completion
of our proposal will illuminate the fundamental role of RAF1 in human cardiogenesis and the molecular
mechanisms underlying CHDs and cardiomyopathy in NS RAF1 at an unprecedented resolution. It will also
provide fundamental new knowledge regarding the transcriptional, epigenetic and protein networks controlling
human cardiac development and will pave the way for follow up studies to design new therapies for NS children
with heart defects. Finally, we anticipate that our study will open new avenues of investigation of other
developmental defects observed in NS and will highlight hiPSCs as a powerful model system to decipher the
molecular mechanisms underlying CHDs.

Public health relevance
Project Narrative Infants with Noonan syndrome present with severe cardiomyopathy and congenital heart defects. This grant explores the role of RAF1 and the impact of Noonan syndrome RAF1 mutations on early human cardiogenesis. Experiments derived from this proposal will allow a comprehensive in-depth interrogation of the RAF1-dependent molecular mechanisms deployed during cardiogenesis and impacted by Noonan syndrome mutations.